Deciphering Molecular Mechanisms of Calcium Homeostasis

PROJECT SUMMARY
Calcium is a critical mediator of many cellular processes, including muscle contraction,
mitochondrial activity, transcription, cell division, and synaptic vesicle release. Paradoxically,
calcium can also trigger cell death and cellular necrosis. Therefore, dysregulation in calcium
signaling can affect cells in different ways and to varying degrees. Consequently, calcium levels
need to be tightly controlled. Indeed, defective calcium signaling has been implicated in many
neurodegenerative diseases, muscular dystrophies and heart disease. To understand the
mechanisms regulating calcium signaling and how defects in this process can lead to cellular
dysfunction, we are exploiting the model system Caenorhabditis elegans to identify critical
processes that are involved in the regulation of calcium handling. We have recently
demonstrated that SEL-12, the C. elegans presenilin ortholog, has a role in mediating
endoplasmic reticulum-mitochondrial calcium homeostasis. Disruption of presenilin function
results in an increase in mitochondrial calcium levels and alters mitochondrial metabolism
promoting protein homeostasis collapse and neurodegeneration. Presenilin is a highly
conserved protein found from plants to humans that is extensively found on endomembrane
structures (e.g., endoplasmic reticulum and lysosome) of most cell types. However, the role
presenilin has in the endomembrane system is not clear. Importantly, mutations in human
presenilin are the most common cause of early onset familial Alzheimer's disease. Despite the
identification of the involvement of presenilin in Alzheimer's disease over 20 years ago, the
functional consequences of mutations in presenilin causing Alzheimer's disease are not
understood. To gain further insight into the role presenilin has in mitochondrial calcium
homeostasis and neuronal fitness, we have developed a novel and highly selective RNA
interference screen to identify gene products that meditate the elevated endoplasmic reticulum
to mitochondrial calcium signaling observed in sel-12 mutants. From this screen, we have
identified several proteins known to mediate endoplasmic reticulum calcium release and
mitochondrial calcium uptake but we also identified several gene products with an
uncharacterized role in endoplasmic reticulum and mitochondrial calcium signaling. We propose
to utilize a multifaceted approach that combines genetic manipulation, high resolution live cell
microscopy to analyze endoplasmic reticulum and mitochondrial dynamics, mitochondrial
activity assays, and behavioral assays to determine the role these gene products as well as sel-
12 have in mitochondrial health and neuronal fitness.

Public health relevance
PROJECT NARRATIVE Deregulation of calcium handling and mitochondrial function is implicated in most if not all neurodegenerative diseases as well as other age-related disease. Thus, the goal of the proposed research project is to resolve the molecular mechanisms underlying calcium regulation and mitochondrial function and, therefore, provide insight into the causes of and strategies to treat neurodegenerative disease.